Uncoupling of IL-1 beta and VEGF-A Crosstalk Contributes to Impaired Arteriogenesis Response to Ischemia in Chronic Diabetes Mellitus

Peripheral artery disease (PAD) caused by atherosclerosis leads to considerable morbidity and mortality
throughout the world, in large part, due to tissue damage from both acute and chronic occlusive ischemia.
Current treatments are limited to the modification of risk factors and mechanical revascularization by
surgical bypass or angioplasty. Preclinical studies have identified mechanisms involving bone marrow
derived macrophage (BMDM)-dependent angiogenesis in an inflammation suppressed state, but there is
also a role for inflammatory macrophages during acute injury to promote effective angiogenesis. We
recently defined a novel IL-1 B-dependent transcriptional regulation of the pro-angiogenic isoform of
VEGF-A. Primary macrophages with deletion of IL-1 B demonstrate impaired expression of VEGF-A, and
consequently, macrophage IL-1 beta-deleted mice have impaired angio/ arteriogenesis. Recent
preliminary data identified that VEGF-R2 (relative to VEGFR1) expression is also elevated in the
inflammatory M1 state and is associated with elevations in IL-1 beta and VEGF-A. Inhibition of
VEGF-R2 signaling led to reduced VEGF-A expression despite stable IL-1 beta levels, suggesting an
uncoupling of the relationship between IL-1 beta and VEGF-A . Additional preliminary data demonstrated
that aged (52-week-old) mice or mice with experimental diabetes have reductions angio/ arteriogenesis,
using a PAD model of femoral artery ligation that involves macrophage-directed blood flow recovery.
Combined aging with chronic diabetes led to further reductions in blood flow recovery consequent to
impaired angiogenesis. Further BMDMs from aged, diabetic mice demonstrated an uncoupling of IL-1 beta
and VEGF-A expression, with modest reductions in IL-1 beta and yet severe and disproportionately
reduced VEGF-A expression. VEGF-R2 was decreased in aged, diabetic BMDMs. Uncoupling of
macrophage IL-1 beta-VEGF-A signaling contributes to impairment of inflammatory angio/arteriogenesis in
the setting of long-term type 2 diabetes. Our study aims seek to define the mechanism whereby
VEGF-R2 facilitates IL-1 beta-dependent VEGF-A production and consequent arteriogenesis and to
determine the impairments in this pathway caused by aging and long-term diabetes with the goal of
intervening to recover effective angiogenesis in the appropriate clinical context.